A multifaceted investigation of speech outcome after maxillary advancement

PROJECT SUMMARY/ABSTRACT
Impaired speech hinders an individual’s ability to effectively communicate in a world that heavily relies on
verbal communication. Children born with cleft palate are at high risk of speech disorders directly
related to atypical anatomy. In addition, approximately 50% of U.S. adolescents and young adults (AYAs)
with cleft palate with or without cleft lip (CP±L) have undergrowth of the upper jaw (maxillary hypoplasia).
Maxillary hypoplasia causes an underbite that has detrimental impacts on articulation (i.e., tongue placement
for speech). Treatment requires surgery to move the upper jaw forward to align the upper and lower jaws, likely
improving articulation. This surgery also changes the anatomic relationship between the soft palate (velum)
and back wall of the throat (pharynx), potentially causing velopharyngeal insufficiency (VPI). VPI is a speech
disorder caused by inability of the velum to close against the pharyngeal wall and causes air to flow through
the nose instead of the mouth when making certain speech sounds. Despite known risk, predictors and
prevalence of VPI after forward movement of the upper jaw in AYAs with CP±L are not well understood.
Limited evidence exists exploring relative improvement in speech articulation and risk of VPI after upper jaw
surgery. Further, data is lacking regarding AYA perception of these risks when making surgical decisions. To
address these gaps in knowledge, we propose a prospective cohort study of 50 AYA with CP±L undergoing
initial maxillary advancement with the following aims: (1) to investigate anatomic risk factors associated with
post-operative VPI, (2) to quantify the relationship between objective or subjective speech measures and
patient-reported outcome, (3) to discover AYA perspectives when considering jaw surgery. Results will further
illuminate risks and benefits of maxillary advancement surgery on speech and inform future surgical decisions.
Candidate: Sara Kinter, PhD is an Assistant Professor, epidemiologist, and speech-language pathologist with
the Department of Pediatrics, Division of Craniofacial Medicine at the University of Washington. This award will
provide the dedicated time necessary to enhance Dr. Kinter’s skill set for successful transition to an
independent investigator. Dr. Kinter’s career development plan includes a combination of didactic, directed,
and experiential learning opportunities focused on: (A) objective measurement of speech structure and
function, (B) qualitative methods, and (C) leadership, grantsmanship, and dissemination in research. The multi-
factorial nature of surgical decision-making as well as the complex relationships between anatomic, functional,
and psychosocial perspectives require a principal investigator with extensive clinical experience in this
population and a strong background in study design. As a speech-language pathologist with over 15 years of
clinical experience who recently earned her Ph.D. in epidemiology, Dr. Kinter is uniquely qualified to carry out
this project and address these important, clinically relevant questions. The proposal will provide a strong
foundation for future high-impact clinical research aimed at improving speech in individuals with CP±L.

Public health relevance
PROJECT NARRATIVE Management of cleft palate with or without cleft lip (CP±L) requires multiple surgeries and multidisciplinary clinical care throughout childhood and maximizing outcome and minimizing burden are important to support long-term health and quality of life. The goal of this research proposal is to investigate speech outcome after maxillary advancement surgery in adolescents and young adults (AYAs) with CP±L from multiple perspectives to elucidate predictors of adverse change, enhance understanding of overall speech outcome, and to hear AYA perspectives of these risks in their own words. This information will be important for informing surgical decision-making and creating a conceptual framework of speech changes following maxillary advancement in this population.